DEVELOPMENT OF ASSAYS FOR STAGE II EVALUATIONS OF NEW ANTI-HIV COMPOUNDS

Prototype antiviral agents are being used to develop and evaluate novel assay systems aimed at elucidating potential mechanisms of action of new compounds identified by the NCI primary anti-HIV screens. The assays define specific stages in the virus life cycle and include a diverse set of biochemical endpoints. Prioritization of new lead compounds is thus facilitated through the derivation of a wider variety of in vitro test data than available from the primary screen.